Ready to CONNECT: Conversation and Language in Autistic Teens

Conversations are a critical medium for success in daily life, but predictors and measures of conversational
success are poorly understood. The overarching goal of this proposal is to identify networks of naturalistic
and standardized psycholinguistic features that lead to successful conversations. Standardized language
assessments often do not capture important linguistic processes in real-world conversations, such as pronominal
reference, back-channeling, turn-taking, or phonological, lexical, or syntactic alignment. The double empathy
theory further posits that autistic conversational difficulties reflect failures of mutual understanding, rather than
autistic deficits, indicating that autistic and neurotypical conversation partners differentially use and understand
these linguistic processes. This proposal centers individuals with autism spectrum disorder who have age-
appropriate scores on standardized language measures, many of whom nonetheless struggle with
communication. We will use machine learning to model conversational profiles based on interactional
measures of linguistic processes drawn from spontaneous conversation, and standardized language
assessments, to evaluate conversational success in neurotype-concordant and neurotype-discordant
interactions. Leveraging the ubiquity of videoconferencing, we will collect clinical and psycholinguistic data from
dyadic conversations in a large sample of 500 12–15-year-old adolescents. We will also collect in-person
conversational data from a group of n = 60. After providing a canonical speech sample, participants will have
conversations with neurotype-concordant and -discordant partners in two contexts: (1) a get to know you
conversation, and (2) a collaborative conversation, in which partners each hold one of a pair of pictures that
differs in five ways and verbally collaborate to find the differences. We objectively define conversational success
as the number and speed of correct identifications in Task 2. In addition, partners will rate their interactions post-
hoc on subjective social metrics (e.g., likeability, warmth, boredom) and conversational success metrics (e.g.,
turn-taking, mutual appreciation, interest in further interaction). Conversations and speech samples will be
recorded and then scored by naïve third-party raters on the same metrics. Recordings will be analyzed for
acoustic, psycholinguistic, and conversational measures (e.g., fundamental frequency, prosodic range, pause
duration, linguistic alignment, turn-taking). We will contrast the power of standardized scores and naturalistic
psycholinguistic measures to predict both subjectively and objectively defined conversational success (Aim 1)
and compare success in neurotype-concordant and neurotype-discordant partnerships (Aim 2). Aim 3 will
leverage this rich dataset of acoustic, linguistic, perceptual, and standardized data to model computational
predictor networks of conversational success. Results will advance the field by establishing metrics of
conversational success in real-world social interactions and using computational models to form meaningful
conversational profile clusters that go beyond simple diagnostic dichotomies to inform personalized supports.

Public health relevance
Autism contains a puzzling conundrum: Although 70% of autistic individuals demonstrate age-appropriate language and cognitive abilities on standardized tests, they nonetheless experience significant communication breakdowns during everyday interactions that negatively affect their social, educational, and occupational outcomes. This proposal advances research and clinical practice by defining clinically meaningful markers of conversational success in 560 autistic and neurotypical adolescents participating in (1) neurotype-concordant (autistic-autistic or neurotypical-neurotypical) and (2) neurotype-discordant (autistic-neurotypical) dyads. By combining traditional standardized language tests with innovative psycholinguistic measures derived from spontaneous natural conversations, a key output of this project will be clinically useful and ecologically valid profiles of communication strengths and weaknesses that can be used to inform personalized interventions focused on improving autistic adolescents’ conversational success.